Regulation and retention of extrachromosomal oncogene amplifications in cancer

PROJECT SUMMARY
Oncogene amplification is a key driver of cancer progression and can either occur within chromosomes or via
formation of circular extrachromosomal DNA (ecDNA). ecDNA is detected in a quarter of cancer samples and
half of all cancer types, and is associated with poor patient outcomes. Despite the prevalence of ecDNA-
mediated oncogene amplification in cancer, we have a limited understanding of how oncogene expression is
regulated on ecDNAs and how these molecules are maintained in cancer cells. My goal is to elucidate how
oncogenes are amplified and dysregulated on ecDNA in cancer using multiplexed genetic perturbations,
epigenomic profiling and novel genetic screening methods in cancer cell line models. In the F99 phase, I will
systematically identify unique transcriptional dependencies of ecDNA-harbored oncogenes. ecDNA is linked to
high levels of oncogene overexpression and accessible chromatin, suggesting that oncogene expression on
ecDNA may be uniquely regulated. In my dissertation work so far, I have used imaging, chromatin conformation
and epigenetic perturbation approaches to discover a novel mechanism by which ecDNAs cluster with one
another in the interphase nucleus and engage in cooperative, intermolecular oncogene activation. These
observations suggest that oncogene expression is regulated differently on extrachromosomal oncogene
amplicons compared to chromosomal loci. I hypothesize that differential regulation of gene expression on ecDNA
depends on unique transcriptional regulators. I will use a combination of flow cytometry, CRISPR screening,
single-cell transcriptomics by Perturb-seq, and bulk epigenomic profiling to identify unique transcriptional
regulators of oncogenes amplified on ecDNA in a panel of cancer cell lines and patient-derived neurospheres.
In the K00 phase, I will elucidate the mechanism of retention of ecDNA-harbored oncogenes in cancer cells.
ecDNA lacks centromeres and is uncoupled from the mitotic spindle during cell division. Therefore, ecDNA
segregates randomly between daughter nuclei. Nevertheless, ecDNA is retained, and even selected for, during
tumorigenesis, suggesting an uncharacterized mechanism for ecDNA segregation. Surprisingly, live cell imaging
during mitosis showed strong colocalization of ecDNA with chromosomes, suggesting that ecDNAs may be able
to co-opt chromosomal segregation mechanisms despite lacking centromeres. I hypothesize that specific genetic
elements on ecDNA enable hitchhiking onto chromosomes in order to partition into daughter nuclei during cancer
cell division. I propose to identify DNA elements and protein mediators that enable retention of ecDNAs using a
shotgun episome-based genetic screen, mitotic chromatin conformation capture, proximity proteomics, CRISPR
screening and integration of epigenomic datasets. Together, elucidating the mechanisms of extrachromosomal
oncogene upregulation and amplicon retention in cancer cells will reveal potential therapeutic opportunities for
ecDNA+ cancers. It will also provide important insights into how organization of the cancer genome and altered
epigenome affect regulation of oncogene expression and ultimately tumor growth.

Public health relevance
PROJECT NARRATIVE As oncogene amplification on extrachromosomal DNA (ecDNA) is frequently detected in cancer, understanding the unique regulation and organization of ecDNAs in cancer cells will enable identification of potential therapeutic opportunities. I propose to elucidate the regulation of oncogene expression on ecDNA and the mechanism of ecDNA retention in cancer cells. This work will identify unique dependencies of ecDNA-derived oncogene expression and ecDNA maintenance and will also provide novel insights into how organization of the cancer genome and altered epigenome affect oncogene regulation and ultimately cancer development.